Clinical Research Core

The WF OAIC Clinical Research Core (CRC) provides essential infrastructure and investigator resources
critical to the successful conduct of clinical research focusing on physical function and disability in older adults.
The CRC is well-integrated with the other OAIC Resource Cores (Bioimaging, Integrative Biology, and
Biostatistics and Research Information Systems). Working closely with them, the CRC will support Research
Education Component (REC)-supported Scholars, OAIC pilot studies, externally-funded studies, and OAIC
Research Development Projects related to the WF OAIC research theme: “Integrating pathways affecting
physical function for new approaches to disability treatment and prevention.”
Under the leadership of Drs. Barbara Nicklas, Jeff Williamson, & Kristen Beavers, the CRC will assist the
Leadership and Administrative Core (LAC), the Pilot and Exploratory Studies Core (PESC), and the REC in
identifying promising new investigators and programs positioned to help address the mechanisms of physical
disability and work to reduce or eliminate age-related dysfunction. The CRC will provide ‘turn-key’ resources
critical for successful clinical research studies, including: 1) expertise related to experimental study design and
conduct, including selection of appropriate outcome measures; 2) highly efficient and effective participant
recruitment; 3) a common assessment battery incorporating key measures important to understanding
changing physical function; and 4) assisting early-career investigators with Internal Review Board and other
regulatory filings (in collaboration with the PESC and REC). In the present cycle, provision of these key
resources has been integral to our timely completion of clinical studies, publication of results, competition for
new independently-funded grants, and development of new investigators.
In the first year of the next cycle, the CRC will support 19 studies: 2 REC Scholar Projects, 2 Pilot and
Exploratory Studies, 1 Development Project, and 14 Externally-funded Projects. The Development Project will
be led by the CRC and its goal will be to increase the generalizability of WF OAIC research by enhancing the
research participation of older adults with lower socio-economic status. The supported studies cover a broad
range of OAIC-themed research, including testing interventions targeting aging-related biologic pathways in
humans, optimizing body composition to improve physical function, incorporating CNS-relevant measures and
concepts into the physical function and disability pathway, and expanding research conduct and disseminating
results across the academic learning healthcare system.